Personalized Antibiotic Therapy in the Emergency Department: PANTHER Trial

Project Summary
Urinary tract infections (UTIs) are one of the most common infections seen in the emergency department (ED)
and one of the most common reasons antibiotics are prescribed in the U.S. Inappropriate antibiotic prescribing
and excessively long durations of therapy are two major causes of increasing antimicrobial resistance.
Standard treatment for patients discharged home from the ED is an oral course of antimicrobial therapy for a
set number of days. Physicians recommend that patients complete the full-course of antimicrobial therapy
regardless of the time of symptom resolution. However, this approach disregards host and pathogen factors
that affect an individual’s unique response to treatment. An alternative approach would be to direct a patient to
discontinue their antibiotics upon symptom resolution, i.e., patient-directed antimicrobial duration (PDAD). A
critical evidence gap is that a patient-centered approach has not been evaluated in clinical trials, but may
decrease unnecessary antibiotic exposure, lowering the risk of adverse events (AEs) and resistance
promotion, while resulting in similar outcomes as those treated with a standard approach.
Antimicrobial resistance has complicated UTI treatment with the prevalence of fluoroquinolone (FQ)-resistant
Escherichia coli now exceeding 20% in some US locations. The Infectious Diseases Society of America
guidelines identified a research gap to understand the role of 3rd generation cephalosporins for outpatient
treatment of acute uncomplicated pyelonephritis (AUP) in the setting of high rates of FQ resistance. The need
for FQ alternative treatments is particularly pressing because of increasing reports of FQ-associated serious
adverse events (SAEs). A critical need exists to identify alternative antimicrobial strategies that could improve
patient outcomes and decrease the risk of AEs and resistance promotion. As opposed to short-course FQ
treatment, for β-lactam regimens, IDSA recommends a 10-14 day treatment duration, thus allowing an
opportunity to explore PDAD to minimize collateral antibiotic damage.
To overcome the inertia associated with the traditional recommendation to complete a full-course treatment
and demonstrate the safety and feasibility of conducting a large randomized controlled trial, we propose a pilot
study comparing PDAD to a fixed indication-specific duration using an oral 3rd generation cephalosporin for
women with AUP treated as outpatients. If our study hypothesis is confirmed, then results from a large clinical
trial will support a paradigm shift in the way antimicrobial therapy is prescribed for patients with AUP and other
common infectious diseases.

Public health relevance
Project Narrative This pilot study will support the feasibility and safety of conducting a large multi-center randomized controlled trial comparing patient-directed antimicrobial treatment duration to a fixed indication-specific duration using an oral 3rd generation cephalosporin for outpatient treatment of women with acute uncomplicated pyelonephritis (AUP). Patients will discontinue therapy upon symptom resolution, which may result in less antibiotic exposure, fewer adverse events, and decreased promotion of antimicrobial resistance. This project potentially will have a significant impact on not only patients being treated for AUP but on how infectious diseases are treated generally, reversing a decades' old approach to prescription of antimicrobial therapy.